Permeability Barrier, Pathogenicity And Antibiotic Resis

Research in my laboratory focuses on the understanding of the mechanisms of bacterial pathogenesis, antibiotic resistance of gram-negative bacteria, and the development of novel antimicrobial agents and vaccines, specifically as they relate to ulcer disease and other bacterial infections. Gram-negative bacteria (pathogens and nonpathogens) have a unique structure called the outer membrane that makes these bacteria more refractory to antibiotic therapy than their gram-positive counterparts (save mycobacteria). Research findings in our laboratory provided the initial genetic and biochemical and recent structural evidence for the role of ADP-L-glycero-D-mannoheptose 6-epimerase (epimerase) in the synthesis of the lipopolysaccharide precursor L-glycero-D-mannoheptose (heptose) in several genera of gram-negative bacteria. Our findings are relevant to the management of infection, built on taking advantage of the observations that gram-negative bacteria with defective heptose biosynthesis have altered growth rate, virulence, increased susceptibility to antibiotics and that heptose is not found in mammalian cells. Therefore, the heptose biosynthetic enzymic steps in bacteria are unique targets for the design of novel antimicrobial agents. Our structural studies of epimerase (done in collaboration with Drs. Steve E. Ealick and Ashley M. Deacon) indicated a high structural similarity to the short-chain dehydrogenases/reductases superfamily and the presence of the conserved catalytic motif TyrXXXLys. Based on these findings, we initiated mutagenic and kinetic studies to confirm a role for Ser116, Tyr140 and Lys144 residues in ADP-L-glycero-D-mannoheptose 6-epimerase catalysis. We constructed several chemically induced or site-directed epimerase mutant proteins (i.e., Y140C, Y140Q, Y140F, Y140H, Y140E, K144I, K144R, and S116A). The specific activity of K144R was only 1.3% of that of the native enzyme with a kcat value that is 2.4 % of the wild type enzyme. Further, the activity of K144I mutant was undetectable. When Tyr140 was substituted with cysteine (Y140C), glutamine (Y140Q), glutamic (Y140E), phenylalanine (Y140F), histidine (Y140H), or alanine (Y140A), the specific activity ranged from 0.61% to 0.19 % of the wild type enzyme activity, while the activity of Y140A was not detectable. Further, when serine 116 was substituted with alanine (S116A), a similar residue but lacks a hydroxyl group, the mutated enzyme had no activity. In summary our results suggest that the phenolic hydroxyl group of tyrosine, the epsilon-amino group of lysine and the hydroxyl group of serine are essential for the catalytic activity of ADP-hep 6-epimerase. In addition, we have demonstrated using epimerase mutants, G6S and G6A, that Gly6 is required for NADP binding and that the secondary structure of G6S mutants of ADP- hep 6-epimerase is lost. We have extended our investigation of the outer membrane to the gram-negative strain, Helicobacter pylori. H. pylori is the causative agent for gastritis, ulcer disease and some gastric cancers. The mechanism of H. pylori pathogenesis is not known at this time. We are using a mouse model for the study of H. pylori infection, detection methods, pathogenic mechanism(s), an in vivo expression technology to identify genes induced during infection. We have developed a non-invasive, sensitive and species-specific method to detect H. pylori infection of mice by PCR analysis of fecal pellets extracts. Our findings demonstrate that the H. pylori presence in mice can be detected reliably over time, thus allowing determination of the persistence/transience of the infection. Furthermore, our findings that the sensitivity in feces was 10 to 100 cells suggesting that it may be directly applicable to detection of H. pylori in feces of other live experimental animals and humans. Another ongoing project has been designed to identify and characterize novel targets for the development of antibiotics and protective vaccines directed against H. pylori. Two LPS core biosynthetic genes (rfaD and rfaE) from H. pylori have been cloned and the gene products purified. This is the first purification and characterization of the rfaE gene product, ADP-D-glycero-D-mannoheptose synthetase, from any gram-negative bacterium. An assay for ADP-D-glycero-D-mannoheptose synthetase has been developed. The rfaE gene encodes a protein with two distinct domains. The two domains of the rfaE gene product have been cloned, expressed, and assayed for enzyme activity. Domain II of the synthetase has been shown to catalyze the formation of ADP-D-glycero-D-mannoheptose from heptose-1-phosphate and ATP. Gel filtration and SDS-PAGE analysis of the purified synthetase revealed that the native enzyme has a molecular mass of 312 kDa and a subunit molecular weight of 52,000. The km and Vmax for the substrate is 0.025 mM and 22.5 nmol/min/mg. The kcat for this enzyme is 0.020 s-1 Additional physico-chemical studies of the synthetase are ongoing. Maltose binding-rfaE fusions have been constructed to increase the yield of soluble protein and crystallization trials are planned for ADP-D-glycero-D-mannoheptose synthetase. To study host requirements for establishing successful infection and subsequent pathogenesis, we have infected mutant C57BL/6 mice with genetic alterations that may influence the virulence of H. pylori. For this study two C57BL/6 mutant mouse strains were selected: an interleukin 10-deficient (IL-10) knockout and p47phox knockout strain. Using these knockout mice, we are evaluating the role of endogenous IL-10 on the regulation of the immune response to H. pylori infection. The p47phox knockout mice have allowed us to examine the in vivo role of NADP oxidase mediated inflammatory responses to Helicobacter pylori infection and pathology. In summary, both the E. coli and H. pylori studies should advance our understanding of LPS core synthesis, gram-negative bacterial infection, pathogenesis and offers ways to manage them.